Core A- Tabin

This Core functions to coordinate activities under the Program Project including organizing monthly meetings and annual visits by the Advisory Committee, facilitating Core utilization and preparing grant-related reports and applications. These activities support all the Projects equally.

Public health relevance
The Administrative Core plays a key role in overseeing the Program Project and allowing it to run smoothly (see above), as such it is critical for the research efforts described in this proposal and hence, for administering research in bone biology.